Defining epigenetic dysregulation in aged hematopoietic stem cells

We have generated transcriptional analysis (mRNA-seq) of HSCs isolated from replicates of young and old age populations. We have additionally evaluated 5 histone marks, ATAC-seq, and ChIP-seq from HSCs purified from both young and aged male C57Bl/6J mice. Age-related changes showed showed significant changes in bivalent domains, contact frequency and overall chromatin structure associated with to aberrant transcriptional profiles. We are currently working to publish these large dataset generated as a resource to the aging and stem cell community.